Center for High-Throughput Minimally-Invasive Radiation Biodosimetry

This Program represents a cohesive approach motivated by the practical needs of very high-throughput
biodosimetry in a variety of different large-scale exposure scenarios, to predict both individual dose and also
individual sensitivity to future injury. A central characteristic remains our focus on 3 different high-throughput
approaches: fully automated cytogenetics (Project 1), gene expression (Project 2), and metabolomics (Project
3). These have different balances of capabilities in terms of throughput, time-to-result, dose reconstruction,
exposure scenario identification and individual radiosensitivity prediction, and the final goal is to quantify their
optimal integrated usage in different large-scale exposure scenarios. The Projects share four common themes:
1: “Beyond Simple Exposures”: Towards High-Throughput Biodosimetry for Complex Exposures: After
an IND there will be a wide variety of exposure scenarios including very high dose rate, neutron exposure,
partial-body exposure (all from the initial prompt radiation), and varying dose rate and low dose rate (from
external fallout and internal exposure). The goals are to 1) understand how these different exposure scenarios
modulate the response of the predictive biomarkers that we have developed, and 2) optimally use these
biomarkers to identify / characterize these different exposure scenarios to which individuals may be exposed.
2: “Beyond Dose”: Towards High-Throughput Individualized Predictors of Photon and Neutron-
Induced Radiosensitivity and Late Radiation Injury: Gene expression and metabolomics each have utility
for predicting individualized onset of late radiation-induced lung disease, and for predicting which irradiated
animals will die from the disease. This work will be extended to neutron-induced late effects, whilst also
assessing the significance of senescent cells for late disease development and for our lung disease signatures.
3: “Beyond Model Systems”: Probing the Applications of Experimentally-Generated Photon and
Neutron Biomarkers to In-Vivo Human Exposure Scenarios: The goal is to assess in-vivo human
exposures, but biodosimetric assay development is typically performed either with ex-vivo irradiated human
blood or in-vivo in animals. For both photons and neutrons, ex-vivo vs. in-vivo generated biomarkers will be
compared, and ex-vivo generated biomarkers from different species will be characterized and compared.
4: Optimized Biomarker Integration: The three different biomarker systems reflect different balances of
capabilities in terms of, for example, throughput, time-to-result, signal lifetime, dose reconstruction, exposure
scenario identification and individual radiosensitivity prediction. The goal here is to identify their optimal
integrated usage in each of a variety of very different possible large-scale exposure scenarios.
Three scientific cores (Animal, Irradiation & Dosimetry, and Biostatistics) bring together key support
technologies, with each Core supporting each of the Research Projects. Because of the integrated nature of
the research, this results in major gains in efficiency.

Public health relevance
This Program represents a cohesive approach motivated by the practical needs of very high-throughput radiation biodosimetry in a variety of very different large-scale exposure scenarios, to estimate past individual dose and to predict individual sensitivity to future injury. A central characteristic remains focus on three different approaches: fully automated cytogenetics, gene expression, and metabolomics; these have different balances of capabilities in terms of throughput, time-to-result, signal lifetime, dose reconstruction, exposure scenario identification and individual radiosensitivity prediction, and the final goal is to quantify their optimal integrated usage in each of the many different potential exposure scenarios.